EFFECT OF GALLIUM NITRATE ON BONE TURNOVER INDICES IN PAGET'S DISEASE

The aim of this study is to evaluate the effects of gallium nitrate on bone resorption indices and calcium balance in patients with Pagets' disease of bone.